Polarity-Mediated Suppression of Tumorigenesis

DESCRIPTION (provided by applicant): The vast majority of human malignancies originate from cells of epithelial origin (carcinomas). Epithelial cells exhibit apical-basal polarity, and lss of apical-basal polarity is considered both a defining characteristic and prerequisite for human cancer. Disruption of epithelial polarity in the setting of infection by oncogenic viruses (e.g. HP) or during breast cancer formation contributes to both cancer development and metastasis. The loss of polarity regulation is also associated with increased proliferation, through mechanisms that are poorly understood. Epithelia are dynamic structures with a high capacity for renewal and repair. In response to injury (genetic mutation, irradiation, physical), JNK-dependent apoptosis is induced and these dying cells secrete various mitogens that induce compensatory proliferation of the surrounding unaffected cells, so as to maintain the integrity of the epitheliu. The precise proximal signals regulating this process are not clear. The Longmore lab recently demonstrated that the Cdc42-containing Cdc42/Par6/aPKC polarity complex regulates proliferation in Drosophila epithelia (imaginal discs), and does so, in part, by limiting Rho activity. Disrupting the formation of the Cdc42/Par6/aPKC complex, but not other polarity complexes, by genetically depleting individual components or inhibiting complex assembly induces JNK-dependent apoptosis and compensatory proliferation following radiation injury. Surprisingly, disruption of the Cdc42/Par6/aPKC complex leads to activation of JNK through the increased ability of Rho and Rok to specifically activate myosin. When apoptosis execution is blocked, Cdc42/Par6/aPKC-depleted tissues exhibit tissue overgrowth (a tumorous phenotype), suggesting that in cancer where apoptotic regulation is compromised, disruption of this polarity complex may contribute to tumor hyperproliferation. The specific signaling changes resulting from Cdc42 depletion remain unknown and will be studied in the aims presented in this research project. The molecular signals proximal and distal to myosin in this pathway will be delineated, and the role myosin plays in the activation of JNK in this context will be determined. Furthermore, this project will aim to study whether these signaling events are unique to Cdc42 depletion or shared following depletion of any of the other known polarity-regulating proteins. These advances will further illustrate how the loss of cell polarity contributes to tumor development and progression.

Public health relevance
PUBLIC HEALTH RELEVANCE: Epithelial cell polarity is crucial for numerous biological processes, and loss of cell polarity is considered both a defining characteristic and prerequisite for cancer development. Disruption of epithelial polarity in the setting of infection by oncogenic viruses or during breast cancer formation contributes to both cancer progression and metastasis. Further understanding of the molecular mechanisms that lead to uncontrolled proliferation and tumor formation following the loss of cell polarity is crucial to the development of better cancer treatments. __SpecificAimsTextDelimiter__ B.2. Specific Aims Disruption in apical-basal polarity of epithelia is an early event in tumor development that is well appreciated to be associated with increased or uncontrolled tumor cell proliferation1. In humans, mice, and Drosophila, polarity disruption is known to contribute to increased primary tumor growth, invasion, and metastasis2,3. However, the specific mechanisms through which epithelial polarity disruption leads to tumor cell proliferation are incompletely understood. Epithelia are dynamic structures with a high capacity for renewal and repair. For example, in response to genetic damage to survival pathways, or physical injury such as radiation JNK-dependent apoptosis of damaged epithelial cells is induced and these "dying" cells secrete mitogens that induce compensatory proliferation of the surrounding unaffected cells, so as to maintain the integrity of the epithelium4. The precise proximal signals or "sensors" regulating this process are not clear. The GTP-binding Rho GTPase proteins (Rho, Cdc42, and Rac) are critical signaling switches activated when cells adhere to one another and are important for the establishment and maintenance of epithelial apical-basal polarity5. The Longmore lab recently demonstrated that the integrity of the Cdc42-containing Par6/aPKC polarity complex regulates apoptosis-induced compensatory proliferation in Drosophila epithelia (imaginal discs) by limiting Rho activity6. Disrupting the formation of the Cdc42/Par6/aPKC complex, but not other polarity complexes, by genetically depleting individual components or inhibiting complex assembly induces JNK-dependent apoptosis and compensatory proliferation following radiation injury. Surprisingly, the Cdc42/Par6/aPKC complex was found to control activation of JNK by limiting Rho/Rho Kinase (Rok)/Myosin activity. How increased Rho activity caused by the disruption of the Cdc42 polarity complex and the resultant increase in myosin activity, activates JNK remains to be determined and is a focus of this proposal. When apoptosis execution is blocked, Cdc42/Par6/aPKC- depleted tissues continue to secrete mitogens and overgrow (a tumorous phenotype), suggesting that in cancer where apoptotic regulation is compromised and polarity disrupted this may contribute to tumor development and provides for a possible mechanism for how loss of cell polarity contributes to tumor development. New data I acquired since joining the lab show that JNK activation resulting from Cdc42 depletion occurs independent of TNF (Eiger/Egr in Drosophila) signaling. This contrasts with the situation that results from loss of other polarity regulators (i.e. Dlg, Scrib - well described tumor suppressors in human cancer), where endocytosis of Egr is required for JNK activation7. This, plus the capacity of the Cdc42/Par6/aPKC complex to limit Rho activity (see above) suggest that Cdc42/Par6/aPKC functions in a unique pathway, distinct from the Dlg/Scrib/Lgl polarity complex, to suppress JNK activation in normal epithelia. To test these hypotheses, I will address the Figure 1: Summary of proposed aims following specific aims: 1. To determine how Rho/Rok/myosin, downstream of disruption of the Cdc42/Par6/aPKC complex, activates JNK to contribute to polarity regulated cell proliferation. The Longmore lab previously demonstrated that disruption of the Cdc42/Par6/aPKC polarity complex induces cell proliferation via Myosin6. However, the role of other upstream regulators of Rho and how Myosin contributes to this process are unclear. Using genetic, biochemical, and biophysical analyses in Drosophila larval epithelia and MDCK cell culture, I will determine specifically how Myosin is involved in activation of the JNK signaling pathway following disruption of the Cdc42/Par6/aPKC polarity complex, and whether other Rho regulators contribute in this pathway. 2: To determine and contrast the mode(s) of JNK activation downstream of the Dlg/Scrib polarity complex disruption versus disruption of the Cdc42/Par6/aPKC complex. Are they overlapping or unique pathways? The molecular signaling events downstream of disruption of the Dlg/Scrib complex are well characterized7,8. Recent experiments in our lab suggest loss of Cdc42 leads to activation of JNK via pathways distinct from loss of Dlg/Scrib. Using genetic analysis of known effectors downstream of Dlg/Scrib depletion and of the members of the JNKKK/JNKK/JNK cascade, I will determine whether disruption of the Cdc42/Par6/aPKC complex results in JNK activation via a unique or shared pathway as compared to disruption of other polarity regulators. !